Regulation of Respiration and Apoptosis by Cytochrome c Phosphorylation.

DESCRIPTION (provided by applicant): We recently discovered that cytochrome c (Cytc) is directly regulated by cell signaling via tyrosine phosphorylation on two distinct sites in mammalian liver and heart, a finding made possible by isolation techniques developed by us that preserve the physiological phosphorylation status of the protein. It is our overall hypothesis that Cytc phosphorylation regulates the two main functions of Cytc, mitochondrial respiration and Cytc release during apoptosis. Our long term goal is to understand the effect of Cytc phosphorylation on respiration and apoptosis and to identify the cell signaling pathways directed to Cytc. Supported by preliminary data, three specific aims will be investigated: 1) to test the hypotheses that Cytc is phosphorylated in vivo in a distinct tissue-specific manner and that this phosphorylation results in structural changes of Cytc; 2) to test the hypotheses that phosphorylation of Cytc leads to controlled respiration and prevents its participation in apoptosis; and 3) to systematically identify mitochondrial tyrosine kinases that phosphorylate Cytc. Phosphorylated Cytc will be isolated from cow liver and heart tissue and structurally characterized using mass spectrometry and protein crystallography (Aim 1). Phosphorylated Cytc will be subjected to functional assays including in vitro respiration and apoptosis measurements, accompanied by mutagenesis studies in vivo with Cytc constructs in a Cytc knockout cell line (Aim 2). Experiments to identify kinases that act on Cytc will include a proteomic approach, kinase localization, and yeast two-hybrid studies (Aim 3). This research is expected to reveal that Cytc, long recognized as a central molecule in respiration and apoptosis, is subject to regulation by cell signaling, opening new opportunities for the understanding and control of those two key biological processes.

Public health relevance
PUBLIC HEALTH RELEVANCE: Our laboratory discovered that Cytochrome c (Cytc), which plays a key role in programmed cell death (apoptosis) and cellular respiration, is regulated by cell signaling networks that reversibly phosphorylate Cytc. In this study, we will analyze the structural changes brought about by phosphorylation, determine whether and to what extent phosphorylation affects the functions of Cytc in apoptosis and respiration, and identify the kinases that phosphorylate Cytc. Since apoptosis and cellular respiration are involved in many diseases such as cancer and neurodegeneration, this study is expected to lead to better understanding and control of such diseases. Our laboratory discovered that Cytochrome c (Cytc), which plays a key role in programmed cell death (apoptosis) and cellular respiration, is regulated by cell signaling networks that reversibly phosphorylate Cytc. In this study, we will analyze the structural changes brought about by phosphorylation, determine whether and to what extent phosphorylation affects the functions of Cytc in apoptosis and respiration, and identify the kinases that phosphorylate Cytc. Since apoptosis and cellular respiration are involved in many diseases such as cancer and neurodegeneration, this study is expected to lead to better understanding and control of such diseases. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Cytochrome c (Cytc) is central to both energy production and apoptosis. In energy production, Cytc is part of the mitochondrial electron transport chain (ETC), donating electrons to cytochrome c oxidase (CcO), which reduces molecular oxygen to water. These reactions are a critical and proposed rate-limiting step in the ETC, which generates the mitochondrial membrane potential essential for the production of ATP. In its role in apoptosis, Cytc is released from the mitochondria under conditions of stress. Cell signaling that targets the mitochondria has not been well studied. We have recently discovered that mammalian Cytc is tyrosine phosphorylated in vivo. Phosphorylation occurs on distinct sites in liver and heart tissue, namely tyrosines 48 and 97. Phosphorylation of Cytc on either site leads to an inhibition of oxygen consumption (healthy or "controlled" respiration, Fig. 1). Analysis of tyrosine 48- and 97-phosphorylated Cytc revealed distinct enzyme kinetics in the reaction with CcO, resulting in a hyperbolic and sigmoidal response, respectively. These findings 1) imply that cell signaling regulates cellular respiration via phosphorylation of Cytc, and 2) suggest differential regulation of Cytc in liver and heart, two tissues with distinct mitochondrial capacity and metabolism. Our long term goal is to understand the role of Cytc regulation in cellular respiration and mitochondria-involved (type II) apoptosis, and to determine the signaling pathways involved. This proposal is designed to reveal new regulatory mechanisms of Cytc through phosphorylation in a tissue-specific manner. Based on our preliminary data we have developed a model shown in figure 1 describing the regulatory transition of reversible phosphorylation of Cytc and its effect on the respiratory and apoptotic pathways. It is our overall hypothesis that phosphorylation of Cytc leads to controlled mitochondrial respiration and protects cells from undergoing apoptosis, whereas its dephosphorylation leads to maximal respiration rates and allows its participation in apoptosis. We are well poised to perform the proposed research because we have established the techniques that allow the analysis of Cytc phosphorylation and its effects under physiological conditions regardless of whether in isolated protein, intact cells, or tissue. We will test three basic hypotheses, based on preliminary data: Specific Aim 1: To test the hypothesis that cytochrome c phosphorylation leads to structural changes. Applying newly developed protocols, phosphorylated Cytc will be isolated to homogeneity from cow liver (Tyr48-phosphorylated) and heart tissue (Tyr97-phosphorylated). Phosphorylated and unphosphorylated Cytc species will be analyzed spectrophotometrically and redox potentials will be determined applying the redox equilibrium method. Phosphorylation sites will be assigned with our phospho-epitope specific antibodies and mass spectrometry, and structural changes will be revealed through X-ray crystallography and compared to the unphosphorylated Cytc. Specific Aim 2: To test the hypothesis that cytochrome c (de)phosphorylation affects mitochondrial respiration and apoptosis. Cytc species that have been purified to homogeneity (Aim 1) will be comprehensively analyzed for their in vitro functionality in respiration and apoptosis. We will generate transgenic cell lines expressing mutant Cytc with phospho-tyrosine residues replaced with phenylalanine or the phosphomimetic amino acid glutamate in Cytc null cells. Functional tests of Cytc variant cells will include subcellular localization, respiration, mitochondrial membrane potential, reactive oxygen species (ROS), ATP levels, and apoptosis. We expect that Cytc phosphorylation allows controlled respiration and protects the cell from apoptosis, whereas the unphosphorylated form is required for apoptosome formation, maximal respiration, and high mitochondrial membrane potentials, a condition under which ROS are produced. [[Specific Aim 3: To identify mitochondrial tyrosine kinases that phosphorylate cytochrome c. Based on preliminary data showing that Cytc can be phosphorylated on two distinct tyrosine residues, Tyr48 and Tyr97, we expect to identify, as a first step, the corresponding mitochondrial tyrosine kinases. Three systematic independent approaches will be applied: a) we will employ an unbiased proteomic approach via mass spectrometry and analyze submitochondrial fractions after affinity enrichment; b) we will perform localization studies of 29 human mitochondrial tyrosine kinases selected using computational methods as candidates for Cytc phosphorylation; and c) we will perform a yeast two-hybrid study with Cytc against the candidate tyrosine kinases. Initial assessment of identified kinase candidates will include overexpression and knockdown experiments together with cell respiration, apoptosis, and phosphorylation assays.]] Fig. 1. Model of Cytc phosphorylation: Under healthy conditions Cytc is phosphorylated, allowing controlled respiration and protecting cells from undergoing apoptosis (green). Cellular stress, e.g., via excessive Ca2+, triggers Cytc dephosphorylation, leading to maximal respiration. It is also dephosphorylated Cytc that can be released from the mitochondria to induce apoptosis (red).